Mechanisms regulating ribosome assembly and function in stem cells and vertebrate development.

Protein synthesis underpins a cell’s decision to growth, proliferate and/or differentiate.2,6,11–14,14,15,18
Understanding how protein synthesis allow cells to perform these fundamental activities is a major challenge in
biology. Therefore, there is a critical need to elucidate the mechanisms determining protein synthesis rates and
whether these mechanisms operate in a cell type-specific manner to impart a new layer of regulation in the
control of gene expression. To explore these questions, two orthogonal, but complementary, research programs,
namely Program 1 and 2, have been designed. Program 1 investigates new factors and mechanisms involved
in the regulated assembly of ribosomes in stem cells. Program 1 is built upon recent studies from my lab and
others demonstrating that stem cells relies on ribosome assembly to ensure adequate protein synthesis rates
and the transition from self-renewal to differentiation.2,3,6,11–14,14,15,18 My lab has characterized the composition of
the small subunit (SSU) processome in human cells, and identified DNA-dependent protein kinase (DNA-PK) as
an RNA-dependent regulator of ribosome assembly and proteins synthesis in hematopoietic stem cells.6 Thus,
the immediate goal of Program 1 is to establish the mechanisms by which DNA-PK regulates ribosome
biogenesis in stem cells. Program 2 explores how customizing ribosome assembly and function contributes to
protein synthesis and selective mRNA translation during embryogenesis. Program 2 is underscored by recent
findings suggesting that ribosomes composition and activity are dynamically regulated in a cell type- and tissue-
specific manner, allowing protein expression to be regulated with exquisite temporal and spatial precision.8,12
The immediate goal of Program 2 is to generate in vivo model systems to understand how the cell creates and
regulates ribosome heterogeneity and the importance of this form of regulation for proper cellular function and
organismal development. To address these, we have generated transgenic zebrafish in which two
compositionally distinct and developmentally regulated ribosomes have been genetically labeled, a unique and
powerful tool to study functional aspects of the ribosome in an in vivo developmental model system. Over the
next five years, we expect Program 1 and 2 to uncover new mechanisms regulating ribosomes assembly and
function in stem cells and vertebrate development and to provide powerful insights into ribosomopathies, tissue-
specific disorders linked to defects in ribosome biogenesis and function.

Public health relevance
The proposed research explores new mechanisms involved in the assembly and function of ribosomes and their role in stem cells and vertebrate development. These mechanisms will provide valuable insights into the role of the translational apparatus in development and disease. The proposed research is relevant to the part of the NIGMS’s mission that pertains to understanding how living systems work: from molecules and cells to whole organisms.